Organization of Retinothalamic Circuits and their Contributions to Visual Processing in Primary Visual Cortex

Project Summary/Abstract
The goal of this proposal is to characterize the connectivity and functional role of specific circuits in the
mammalian visual system. This proposal focuses on neural circuits that transmit visual information from retinal
ganglion cells (RGCs) in the retina, through different regions of the dorsal lateral geniculate nucleus (dLGN) in
the thalamus, to specific populations of neurons in the primary visual cortex (V1). The combined activity of
these visual pathway circuits results in the generation of tuning properties in V1 neurons (eg. direction
selectivity) that make important contributions to visual perception and behavior. The objective of this proposal
is to understand how specific retino-geniculo-cortical circuits, carrying different types of visual information,
influence the response properties of V1 neurons in the mouse visual system. The central hypotheses of this
proposal are: (1) There are at least three distinct pathways in the dLGN carrying information from different
types of motion-tuned retinal ganglion cells (mt-RGCs) and non-motion-tuned retinal ganglion cells (nmt-
RGCs) to V1 neurons; (2) These pathways make unique contributions to tuning properties of V1 neurons; and
(3) Motion-tuned and non-motion-tuned information originating in the retina, and delivered via the dLGN to V1
neurons, make specific contributions to the generation of tuning in V1 neurons. The experiments outlined in
this proposal will test these hypotheses by pursuing three specific aims: (1) Establishing the molecular identity
of the neurons that comprise these dLGN pathways, determining how inputs from mt-RGCs and nmt-RGCs are
delivered to them, and identifying which neurons they contact in V1; (2) Determining how input from neurons in
these dLGN pathways influence response properties in identified populations of V1 neurons; and (3)
Determining the contribution that mt-RGCs and nmt-RGCs make to response properties in specific populations
of V1 neurons. This proposal is technologically innovative: it will use a combination of a novel form of
anterograde circuit tracing, single-cell RNA sequencing, chemogenetic silencing, and two-photon calcium
imaging to accomplish its aims. The proposed research will yield significant findings answering fundamental
questions about how information is encoded, processed, and ultimately transmitted throughout the pathways of
the visual system. Answering these types of fundamental questions is of utmost importance because the
computations performed by these pathways generate response properties in neurons that give rise to visual
perception and behavior. Understanding how the visual system gives rise to our sense of the world around us
is a critical first step toward successfully developing strategies to treat a wide range of diseases of the visual
system. Indeed, this is the long-term goal of any visual system research program, and work proposed here will
unequivocally move us closer to both of this goal.

Public health relevance
Project Narrative This proposal seeks to understand, at the level of cells and neural circuits, how visual information is detected and processed by the visual system so that it can contribute to our perception of the world around us. The discoveries made by this proposal regarding the function and organization of healthy visual system circuits will facilitate our understanding of how these circuits could be impacted by disease, and will help speed the advent of therapies designed to treat damage to, and diseases that afflict, the visual system and lead to blindness. More generally, understanding the mechanisms and neural circuits responsible for normal functioning of the visual system has important implications for a range of other diseases in other parts of the nervous system where impairment in the function of neural circuits has been implicated.